Real-time imaging of skeletal muscle innervating sensory neurons that signal pain and fatigue

Muscle pain and fatigue affect nearly all people at some time in their lives. At present, effective treatments for
short term muscle pain are clearly inadequate and adequate treatment for chronic muscle pain is even worse.
Considerable evidence indicates that peripheral sensory dysregulation of group III/IV muscle afferents, and
autonomic dysregulation may cause or contribute to both short-term and chronic muscle pain and fatigue.Our
long term goal is to determine the fundamental mechanisms that signal intense muscle pain, ache and fatigue
to sensory and motor systems. We have previously used discoveries in mouse models to prove that
combinations of protons, lactate, and ATP are necessary and sufficient to activate muscle sensory neurons. In
translational studies in human subjects we showed that combination of these three metabolites activated the
sensations of muscle ache and fatigue in human subjects. We propose here to use several transgenic mice
that will make it possible, for the first time, to determine the molecular, cellular, and structural mechanisms of
the sensory signaling pathways for the cognitive sensations of muscle pain and muscle fatigue. These mice
will also make it possible for us to determine the many different types of afferents that selectively signal the
many different aspects of autonomic function that allow us to function over a wide range of muscle blood flow.
Finally, these mice will make it possible for us to directly image not only the cell bodies of the muscle
innervating neurons, but to directly observe the activation of the nerve endings in skeletal muscles by both
metabolites and mechanical stimulation. These images may allow us to determine the mechanisms for “trigger
points”, the pulsating nature of muscle ache, lymphatic disease associated with muscle fatigue and pain, and
sympathetic activation of enhanced muscle pain.
The specific aims of this proposal are:
Aim 1: Define the different types of mechanosensitive, and metabosensitive sensory neurons
innervating skeletal muscle based on their responses to muscle contraction.
Aim 2: Determine if chemical mediators produced during muscle contraction are responsible for the
potentiation seen among a subset of mechanosensitive muscle sensory neurons during muscle
contraction.
Aim 3: Determine if metaboreceptors and metabo-nociceptors also respond to mechanical forces
generated during muscle contraction.
Aim 4: Determine the location and structure of skeletal muscle sensory neurons signaling pain and
fatigue via direct imaging of neuron terminals.

Public health relevance
Muscle pain and fatigue affect nearly all people at some time in their lives costing over 800 billion dollars each year in medical costs. At present, effective treatments for short term muscle pain are clearly inadequate and adequate treatment for chronic muscle pain is even worse. Our goal is to use state of the art transgenic mice to determine the fundamental mechanisms that signal intense muscle pain, ache and fatigue to sensory and motor systems so that we and others can develop rational treatments for muscle pain and fatigue.